Coordination chemistry approaches to target cellular metal dysregulation

PROJECT SUMMARY
Several transition metals are essential nutrients in human physiology: their acquisition and distribution are
highly regulated, and alterations of metal homeostasis are associated with multiple pathological conditions
including neurodegeneration and cancer. Metal-binding pharmaceuticals are employed clinically to treat metal
overload; however, these chelators target systemic metals rather than intracellular metal dysregulation. Our
research program aims at the design of chelation systems to increase the current understanding of metals in
disease conditions and to modulate metal dysregulation for therapeutic applications in the long term.
Our current experimental focus is on the role of iron in cancer progression. Because malignant cells require
higher iron levels to sustain fast proliferation rates, we are engineering antiproliferative chelators that are
activated upon cellular uptake to interfere with the availability of the labile iron pool. We employ disulfide bonds
and arylsulfonate moieties as activation switches in prochelators that are activated following reaction with
abundant thiols intracellularly. Exploiting the physiological differences between malignant and normal cells, we
design bioconjugation approaches that increase the selectivity of prochelators for cancer cells. Further
enhancing selectivity, we will also pursue the activation of prochelators by specific proteins that are
overexpressed (or uniquely expressed) in cancer cells. In addition, we will deploy pro-oxidant strategies that
enlist the redox chemistry of chelator-bound iron and copper complexes to generate reactive oxygen species in
targeted cells. A new class of prochelators based on tetrazolium cations will be employed to pilot an initiative to
image iron chelation via photoacoustic methods.
Our experimental approach blends principles of coordination chemistry and chemical biology to produce a
new generation of advanced chelation strategies. Detailed mechanistic studies will delineate the cellular uptake
of our prochelators as well as their impact on cell cycle, cell death, and iron signaling. Because iron is a
fundamental player in malignant behavior, this research offers opportunities to impact a broad spectrum of
cancer phenotypes. These molecular design strategies are poised to enhance the scope of chelation in cancer
research and potentially in other pathological conditions associated with metal dysregulation.

Public health relevance
NARRATIVE Alterations of metal homeostasis are characteristic of multiple pathologies, including neurodegeneration and cancer. A reprogrammed iron metabolism is a key descriptor of malignant cells, which maintain increased iron acquisition and retention. With the long-term goal of improving the current understanding of iron dysregulation in human disease and its potential impact on cancer treatment, this research program focuses on the synthesis and biological evaluation of a new generation of selective molecular tools for intracellular iron binding.